3D-bioprinting of probiotic bacterial interference catheters for prevention of catheter-associated urinary tract infections

DESCRIPTION
Catheter-associated urinary tract infection (CAUTI) is a costly clinical problem that affects millions of patients
worldwide. CAUTI are characterized by infection of the bladder and pathogen colonization of the catheter
surface, making them especially difficult to treat. Catheter modifications have been employed to reduce pathogen
colonization, including infusion of antibiotics. However, with a rise in antibiotic resistance among uropathogen
strains, there is a great need to develop alternative strategies for effective CAUTI treatment and prevention.
Lactobacillus probiotics offer promise for a “bacterial interference” approach to prevent CAUTI because they not
only could compete for adhesion to the catheter surface but they also produce and secrete antimicrobial
compounds that are effective against uropathogens. Three-dimensional (3D)-bioprinting has enabled fabrication
of well-defined, cell-laden architectures with tailored release of active agents. We hypothesized that 3D-
bioprinting could offer a novel means for sustained probiotic delivery. We have capitalized on this technology to
design and fabricate a prototype 3D-bioprinted catheter tubing containing the widely used probiotic strain
Lactobacillus rhamnosus GG. Our preliminary data already demonstrate that our initial bioprint prototype 1)
maintains probiotic viability upon extended storage, 2) displays sustained release of live L. rhamnosus, lactic
acid and hydrogen peroxide in vitro, 3) develops surface-associated L. rhamnosus biofilms, 4) inhibits
uropathogenic E. coli in vitro and 4) maintains L. rhamnosus viability and release in vivo in a mouse model. Here,
we will test the overarching hypothesis that the combination of probiotic bacterial interference and 3D-
bioprinting technologies provides an optimal framework for effective CAUTI prevention The objective of
this proposal is to optimize the design and fabrication of Lactobacillus 3D bioprints and to confirm their safety
and efficacy in vitro and in a preclinical mouse model, while advancing our understanding of probiotic interactions
with the host and uropathogenic bacteria.
Successful completion of the aims will deliver validated 3D-bioprinted prototypes that accomplish long-acting
delivery of probiotic species that ultimately improve outcomes in preclinical models of CAUTI. These studies will
provide the foundation for translation to reduce risks associated with urinary catheterization, while providing new
insights into the effects of lactic acid-based and probiotic therapeutics on host inflammatory response and CAUTI
disease markers and progression. Moreover, outcomes of this research will have a significant impact on the
development of future probiotic approaches in the context of other medical device-associated infections. The
successful completion of this project will deliver validated 3D-printed prototypes that enable long-acting delivery
of probiotic bacteria for the prevention and treatment of CAUTI.

Public health relevance
NARRATIVE Catheter-associated urinary tract infections (CAUTI) account for 40% of nosocomial infections globally, amounting to more than 1 million cases in the US alone, and costing nearly $2 billion annually. Current approaches to modify urinary catheters and materials to reduce microbial contamination have several drawbacks that limit their efficacy, and new catheter modifications that capitalize on the strengths of each approach are needed. In this project we will use 3D-printing to develop and test new 3D-bioprinted probiotic catheter devices that combine the strengths of “bacterial interference” at the catheter interface with the release of biocidal agents into the bladder and catheter lumen to preclude or disrupt CAUTI pathogenesis, while advancing our understanding of probiotic interactions with the host and uropathogenic bacteria.